Examining Tobacco Use Relapse among Cancer Survivors

PROJECT SUMMARY
1 Cancer survivors that use tobacco are at a greater risk of experiencing negative health outcomes. While many
2 cancer survivors quit using tobacco at time of diagnosis, available research demonstrates that many
3 relapse (e.g., 13-60%). The Social Ecological Model (SEM) provides a conceptual framework for
4 understanding the intrapersonal factors and interpersonal factors that may contribute to tobacco use relapse.
5 However, to date, few studies have identified intrapersonal and interpersonal predictors of tobacco use relapse
6 among this patient population. Further, these studies utilize survey designs that are unable to examine the
7 factors that immediately precede tobacco relapse. Thus, it is relatively unknown how intrapersonal and
8 interpersonal factors relate to tobacco relapse within the context of cancer survivorship in real-time.
9 The proposed study aims to address this critical gap and advance cancer prevention and control science
10 through using multiple survey methods (i.e., ecological momentary assessment, longitudinal survey) to
11 examine the momentary and long-term associations between intrapersonal factors (i.e., cancer worry, negative
12 affect), interpersonal factors (i.e., social support, social constraint), and tobacco relapse behavior. Cancer
13 survivors that demonstrate greater risk of relapse (e.g., newly diagnosed, recently quit using tobacco) (N=122)
14 will be recruited from VCU Massey Cancer Center and asked to complete a baseline survey and a 3-month
15 follow-up survey to examine intrapersonal and interpersonal predictors of tobacco use relapse (i.e., continued
16 tobacco use for > 7 days). A subset of 40 participants will also complete a 14-day ecological momentary
17 assessment (EMA) to investigate momentary intrapersonal and interpersonal predictors of greater tobacco
18 relapse risk (defined as higher urge to use tobacco and lower motivation to abstain from tobacco). Specifically,
19 the applicant aims to: (1) examine daily associations between intrapersonal factors (i.e., cancer worry, negative
20 affect) and tobacco relapse risk across a 14-day period; (2) examine daily associations between interpersonal
21 factors (i.e., social support, social constraint) and tobacco relapse risk across a 14-day period; and (3) examine
22 the association between baseline intrapersonal and interpersonal factors and tobacco use relapse at follow-up.
23 The proposed training goals for this NRSA fellowship are: (1) increase the applicant’s knowledge of the factors
24 that contribute to tobacco use and tobacco relapse among cancer survivors; (2) enhance training in advanced
25 quantitative statistical methods; and (3) improve translational research-related skills. This training plan involves
26 a variety of research, didactic and professional development-related activities that will facilitate the successful
27 completion of the proposed project and equip the applicant with the skillset needed to lead a career as an
28 independent researcher. Further, the applicant’s mentorship team includes experts within the field of cancer
29 prevention and tobacco control who maintain a history of collaboration. Overall, results from this project have
30 the potential to inform the development of future tobacco treatment programs for cancer survivors.

Public health relevance
PROJECT NARRATIVE While many cancer survivors will quit using tobacco after receiving a cancer diagnosis, many (13-60%) will go on to relapse due to reasons that are still not well understood. Intrapersonal factors (e.g., cancer worry, negative affect) and interpersonal factors (e.g., social support, social constraint) may play a role, but research has yet to examine their momentary or longitudinal influence on tobacco use relapse or risk of tobacco relapse among cancer survivors. This F31 NRSA award will provide the support to complete the proposed project, which aims to examine these predictors’ relation to tobacco use relapse using multiple methodologies (i.e., ecological momentary assessment, longitudinal survey), as well as provide the applicant with support to receive advanced training needed to pursue an independent research career in cancer prevention and tobacco control.